Improving Diabetes Care and Outcomes on the South Side of Chicago

DESCRIPTION (provided by applicant): Racial/ethnic and socioeconomic disparities in the quality of care and outcomes of patients with diabetes have been widely documented, yet relatively little is known about how to reduce these differences. In particular, innovative, sustainable models to improve regional diabetes care are desperately needed that take into account the cultural, racial, organizational, and economic realities of the urban health setting. Previously the investigators have systematically identified gaps in the literature regarding effective interventions to reduce diabetes disparities. This proposal seeks to address these knowledge gaps in an innovative, sustainable way that can be replicated in other areas of the country. The primary goal is to test whether a multi-factorial intervention can improve the quality of care and outcomes of diabetes patients living in predominantly low- income African-American communities, through collaboration between community health centers, an academic medical center, and community-based organizations. The Specific Aims are: 1) To test the effectiveness of a collaborative model program implemented within six clinics on the South Side of Chicago on the quality of diabetes care and outcomes. This multi-factorial intervention incorporates culturally tailored patient activation, cultural competency and communication training for clinicians, and clinic redesign with patient advocates, a quality improvement collaborative, care management, and enhanced community partnerships. The intervention also seeks to increase the number of persons with diabetes from underserved populations who access comprehensive care in safety net health centers through patient advocates and partnerships with community- based organizations. 2) To identify the costs of intervention implementation from the business case perspective of the outpatient clinics and from a societal perspective. 3) To determine the major barriers and solutions to successfully implementing this regional intervention. The study team has expertise in outcomes research, culturally tailored behavioral change, cultural competency training, regional quality improvement collaboratives, race studies, economic analyses, organizational theory, and community-based participatory research.

Public health relevance
PUBLIC HEALTH RELEVANCE: Innovative, sustainable models to improve regional diabetes care are desperately needed that take into account the cultural, racial, organizational, and economic realities of the urban health setting. This proposal seeks to address acknowledged gaps in an innovative, sustainable way that can be replicated in other areas of the country. The primary goal is to test whether a multi-factorial intervention can improve the quality of care and outcomes of diabetes patients living in predominantly low-income African-American communities, through collaboration between community health centers, an academic medical center, and community-based organizations. Innovative, sustainable models to improve regional diabetes care are desperately needed that take into account the cultural, racial, organizational, and economic realities of the urban health setting. This proposal seeks to address acknowledged gaps in an innovative, sustainable way that can be replicated in other areas of the country. The primary goal is to test whether a multi-factorial intervention can improve the quality of care and outcomes of diabetes patients living in predominantly low-income African-American communities, through collaboration between community health centers, an academic medical center, and community-based organizations. __SpecificAimsTextDelimiter__ I. Specific Aims Racial/ethnic and socioeconomic disparities in the quality of care and outcomes of patients with diabetes have been widely documented [1], yet relatively little is known about how to reduce these disparities on a regional basis [2]. Relatively little research has studied what interventions might reduce diabetes disparities [3], and most studies have essentially been efficacy studies in a single or limited number of settings. We propose improving the quality of care and outcomes of patients with diabetes on the South Side of Chicago. The diabetic population on the South Side is mostly African-American and many patients have significant socioeconomic challenges. The health care resources on the South Side also present the challenge of how to coordinate the strengths of community clinics, an academic medical center, and community-based organizations in a way that serves the population and is economically viable for all partners. Currently the University of Chicago and community partners on the South Side are embarking on a major Urban Health Initiative to improve population health in this geographic region. This alignment of interests presents a major opportunity to improve diabetes care with a multi-factorial, collaborative approach. Therefore, our South Side Diabetes Project has the following Specific Aims: 1) To test the effectiveness of a collaborative model program implemented within six clinics on the South Side of Chicago on the quality of diabetes care and outcomes. This multi-factorial intervention incorporates culturally tailored patient activation, cultural competency and communication training for clinicians, and clinic redesign with quality improvement and care management, and enhanced community partnerships. The intervention also seeks to increase the number of persons with diabetes from underserved populations who access comprehensive care in safety net health centers through patient advocates and partnerships with community-based organizations. ¿ H1: Diabetes processes of care and outcomes will improve more within the participating health clinics than in control clinics. ¿ H2: Patients who participate in the patient activation intervention will have greater reductions in their glycosylated hemoglobin (HbA1c) than other patients within the same health centers and within control health centers. 2) To evaluate the cost-effectiveness and financial impact of the South Side Diabetes Project from a long-term societal perspective and to quantify the financial impact of the intervention from the business perspective of the outpatient clinic. ¿ H1: From a societal perspective, the South Side Diabetes Project will be a cost-effective intervention based on traditional incremental cost-effectiveness ratio thresholds (< $100,000 / Quality-Adjusted Life Year [QALY]). ¿ H2: For the business case, the balance of revenues and costs will be highly dependent upon each clinic's payor mix, especially the proportion of Medicaid and uninsured patients. 3) To determine the major barriers and solutions to successfully implementing this regional intervention. ¿ H1: We have no formal hypotheses since we are primarily using qualitative case studies with a grounded theory approach, but we expect organizational motivation, finances and resources, and coordination of the multidisciplinary team and partners to be critical. Our trans-disciplinary team has extensive experience reducing diabetes disparities and improving African- American health, and our study will provide important information for other regions seeking to reduce racial/ethnic disparities in diabetes care and outcomes. Key elements include the integration of clinics and the community, recognition of the socioeconomic challenges of the South Side of Chicago as well as the formidable strengths in the community, examination of the economic ramifications of the intervention, and analysis of the implementation process. We aim for our project to be innovative and practically useful. Improving the health of the South Side of Chicago as embodied by the Urban Health Initiative is a strategic priority of the University of Chicago. Our project's alignment with the Urban Health Initiative, the tailoring of the intervention with the six clinics to what is feasible, and the integration with the community give our intervention a high likelihood of being sustained. Because this proposal was described by the original reviewers as being 'highly significant' and having a 'strong research team' with an 'excellent environment and institutional commitment', we have significantly reduced the 'Background and Significance' and 'Preliminary Studies' sections in order to adequately address reviewer concerns about the research methods and study design.